Role of Sam68 in Proinflammatory Signaling

Abstract
Ulcerative colitis (UC) is a chronic form of inflammatory bowel disease (IBD) with no cure. Current treatment
strategies offer only partial remission, with many patients remaining refractory to treatment, and carry risks of
significant adverse events including serious infections and cancer. Thus, an improved understanding of
inflammatory signaling pathways and identification of novel preclinical mechanisms are critical challenges in
IBD research. Signaling downstream of the proinflammatory cytokine tumor necrosis factor (TNF) and toll like
receptor (TLR) pathways play major roles in IBD pathogenesis. In previous work, we discovered that the RNA
binding protein Sam68 is required for both TNF- and TLR-induced activation of the transcription factor NF-κB,
a master regulator of inflammation, suggesting that Sam68 contributes to NF-κB-dependent inflammation.
Our new preliminary results show that Sam68 is prominently expressed in human and murine intestinal
epithelial cells (IEC); Sam68 knockout (KO) mice are significantly protected from dextran sulfate sodium
(DSS)- and oxazolone-induced colitis; and Sam68 protein is significantly elevated in inflamed colons of UC
patients. Based on this, we hypothesize that Sam68 is a critical mediator of inflammation in IECs, and
targeting IEC Sam68 will provide a novel therapeutic strategy in UC via dual inhibition of TNF- and
TLR-mediated inflammatory pathways. We propose to study the molecular mechanisms of IEC-specific
Sam68 signaling in human and experimental murine colitis using cutting edge tools such as 3D colonoids
derived from UC patient colonocytes and novel IEC-specific Sam68 conditional KO (cKO) mice. Aim 1 will
delineate molecular mechanisms of IEC-specific Sam68 signaling in TNF- and TLR-induced inflammatory
signaling and identify the structural domains and posttranslational modifications of Sam68 required for its
inflammatory functions. Aim 2 will study the in vivo role(s) of Sam68 in primary IECs under homeostatic and
inflammatory conditions, using Sam68-cKO mice challenged with DSS and oxazolone as experimental colitis
models, and using a spontaneous colitis model, Sam68-cKO / Wiscott Aldrich Syndrome Protein (WASP) KO
double KO mice. This aim will utilize 3D colonoids prepared from wild type and Sam68-KO mice to study role
of Sam68 in IEC proliferation, permeability and inflammatory signaling to study the homeostatic role of Sam68.
Aim 3 will delineate the proinflammatory role of Sam68 in UC patients. This aim will study IEC-specific growth,
proliferation, apoptosis, and expression of TJ proteins, and activation of proinflammatory signaling in IEC's and
mucosal immune cells using co-culture assays of control and patient derived 3D intestinal organoids and
immune cells. Successful completion of this study will fill critical knowledge gaps in understanding novel
mechanisms underlying TNF- and TLR-dependent inflammatory signaling in UC and pave the way for the
development of novel therapeutics targeting Sam68 to treat UC. Moreover, this study will also serve as the
basis to explore the role of Sam68 in other TNF- and TLR-dependent chronic inflammatory diseases as well.

Public health relevance
Project Narrative Ulcerative colitis (UC) is an inflammatory bowel disease (IBD) affecting over 1 million people in the United States and its incidence is increasing. Our study addresses the challenge of identifying preclinical human IBD mechanisms and focuses on the role of the protein Sam68 as a critical mediator of tumor necrosis factor (TNF) and toll like receptor (TLR) induced inflammation in UC. Successful completion of this study will reveal Sam68 as a key player in UC pathogenesis and lead to the design of novel therapeutics targeting Sam68 for chronic inflammatory conditions.